A multi-scale systems biology framework for understanding and engineering the human gut microbiome

Metabolites produced by gut bacteria that shape our immune system, metabolism and behavior are dictated by
complex and dynamic multi-scale interaction networks spanning gene regulatory networks (GRNs) within each
cell to inter-species interactions at the community-level. A major knowledge gap is deciphering the networks
driving production of these metabolites and developing the capability to predict these key functions and their
effects on host phenotypes. By developing and applying a novel generalizable systems biology framework, we
propose to revolutionize our ability to quantitatively study microbiomes and discover their ecological and
molecular principles. We will apply this framework investigate major health-relevant metabolites including short
chain fatty acids, bile acid metabolism, trimethylamine, tryptophan metabolism and hydrogen sulfide. Since
combinations of gut microbial metabolites can have synergistic or antagonistic effects on host phenotypes, we
will interrogate the effects of human gut communities on intestinal barrier integrity, a critical regulator of
homeostasis and dysbiosis in the human gut and modulation of T-cell activity. Finally, we will use germ-free mice
as a mammalian gut model to study the dynamics and functions of these communities in vivo.
We will exploit the bottom-up construction of human gut communities in vitro to elucidate the quantitative
contributions of environmental factors (e.g. dietary fibers), species and their interactions on community functions.
Since our in vitro media is a major variable determining experimental outcomes, we will develop a systematic
pipeline for media design that maximizes agreement between in vivo and in vitro community dynamics and
functions. For species selections, we will use (1) a novel data driven computational model that maps genotype
to function to prioritize species based on their predicted effects on target functions and (2) state-of-the-art
ultrahigh-throughput techniques to screen millions of sub-communities by combining droplet microfluidics and
fluorescence activated cell sorting to enrich for sub-communities containing significant inter-species interaction
impacting community functions. Equipped with a designed media and human gut community, we will explore a
large experimental design landscape of combinations of bacteria and environmental factors using a scalable and
flexible machine learning (ML) model coupled to Bayesian optimization to maximize information from limited
experiments. In addition to building a predictive model that can be used to predict system behaviors and decipher
significant interactions, a major goal is to narrow the design space to elucidate the molecular principles of
communities with desired community functions. Using these communities, we will deduce the nonlinear ordinary
differential equations governing community dynamics to reveal interaction modalities. Finally, we will illuminate
GRNs from transcriptional profiles and map these features to community functions using novel ML models. Our
predictive models can elucidate complex webs of interactions linking environmental factors, species, genes,
GRNs and gut microbial metabolites.

Public health relevance
The human gut microbiome consists of trillions of bacteria that shape our immune system, metabolism and behavior via a myriad of bioactive microbial metabolites. These metabolites are produced by complex and dynamic multi-scale interaction networks spanning gene regulatory networks within individual cells to the inter- species interactions at the community-level. We will revolutionize our ability to decipher these interaction networks by combining construction of human gut communities from the bottom-up, state-of-the-art techniques for high-throughput community characterization, advanced computational models of different resolutions, multi- objective optimization and quantitative measurements of host phenotypes using in vitro and germ-free mouse models.